CULTURALLY CENTERED MED. ASSISTED TREATMENT OUD IMPLEMENTATION FOR PRIMARY CARE AND ADDICTION TREATMENT PROGRAMS SERVING AI/AN (CTN-0096). 03/01/2022 - 11/01/2024. DSC6. 75N95023F00001 (TO5).

HEAL Data and Statistics Contract (DSC6) - EXPANSION

This contract is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction and to develop concrete strategies capable of providing rapid and durable solutions to the opioid crisis.